Osage Community Supported Agriculture Study (OCSA)

PROJECT SUMMARY/ABSTRACT
The food system is comprised of food production, access, and marketing. Public health efforts have been
increasingly focused on food systems given that poor diet is the number one risk factor for preventable disease
in the United States. American Indians (AIs) experience substantial diet-related health disparities: AI adults are
50% more likely to be obese, 30% more likely to have hypertension, and twice as likely to have diabetes
compared to Whites. In 2013, the Osage Nation in Oklahoma launched Bird Creek Farm (BCF) with the mission
to facilitate Indigenous food sovereignty, defined as the right and responsibility of Indigenous peoples to healthy
and culturally appropriate foods produced through traditional Indigenous practices. By 2015, BCF had 12
employees and began providing food to tribal programs. In the same year, in collaboration with BCF, our team
launched the NIMHD-funded FRESH farm-to-school program (R01MD011266). Preliminary findings from this
tribally-driven community-based participatory research (CBPR) study show an increase in vegetable and fruit
intake among children and adults and a decrease in food insecurity. Building upon our eight-year CBPR
partnership, the proposed study will implement a new community supported agriculture (CSA) program in which
Osage citizens will receive a weekly share of freshly grown farm produce for 6 months. CSAs have improved
diet and health in non-AI populations, and are evidence-based strategies recommended by the Centers for
Disease Control and Prevention and the Institute of Medicine to reduce health disparities, but no randomized
controlled trial of a CSA program has been conducted in the AI population. Accordingly, we will test the efficacy
of a CSA program combined with culturally-tailored nutrition and cooking education on diet and health outcomes
among Osage adults, evaluate its cost-effectiveness, and develop a multimedia toolkit for disseminating findings.
Our specific aims are to: 1) Conduct a randomized controlled trial to test the newly developed CSA program’s
effect on diet, blood pressure, and blood lipids (primary outcomes) and on body mass index (BMI), hemoglobin
A1c (HbA1c), food insecurity, and health status (secondary outcomes) among 600 AI adults (aged 18-75) with
overweight/obesity; 2) Perform an economic evaluation for individual (e.g., health-related quality of life),
organizational (e.g., healthcare utilization costs), and community-level (e.g., prevention of cardiometabolic
diseases) outcomes; and 3) Document and disseminate study processes and findings using participatory video
methods, and compile a web-based toolkit for other AI communities to use CBPR to improve tribal food systems.
This study is the first to rigorously intervene across all components of the food system to address poor diet and
health among AIs. Building upon Osage Nation assets and priorities, guided by a CBPR and Indigenous food
sovereignty orientation, and based upon recommended strategies to eliminate disparities, study findings will
inform research and policy efforts to create sustainable food access in reservations with high rates of chronic
disease as well as urban AI communities where CSAs are available and could be tailored to AIs.

Public health relevance
Project Narrative American Indians (AIs) have limited access to healthy food and a high prevalence of diet-related diseases. This study will implement a tribal community supported agriculture program in which AI adults receive a weekly box of local fresh fruits and vegetables along with culturally tailored nutrition and cooking education. The program’s effect on diet and health outcomes and it’s cost-effectiveness will be evaluated, and study processes and findings will be broadly disseminated to support tribes in improving diet and health.